Wildfires and arrhythmias: evaluating associations and intervention strategies

The primary goal of this study is to acquire preliminary data to support a future R01-level investigation. The focus of this future trial will be to examine the efficacy of a novel approach to preventing physical frailty, which we have developed in our pilot work: Café Move. Café Move uses simple yet robust assessments of strength, mobility and balance to enable people to quickly and easily gain insight to their physical function, relative to normative data (accounting for age, height, etc.). All of the Café Move assessments can be performed outside of formal healthcare settings (e.g., in a person’s home), thus promoting autonomy and reducing barriers to access. In this study, we plan to make Café Move available in select independent-living senior communities via three modalities (“dine-in,” “kiosk,” and “delivery”). The “dine-in” option will involve face-to-face assessments at scheduled community events. The “kiosk” option will be available via Café Move stations hosted locally within the community, analogous to a blood pressure check station at the local drug store; trained personnel are nearby, but people can interact with the platform on their own. Finally, the “delivery” option will allow people to order the (inexpensive) assessment supplies and perform measurements in their own home. We will conduct a double-baseline cohort study intended to yield the data necessary to calculate within- and between-site variance in the outcome measures of interest (e.g., health behaviors, rates of engagement with prevention strategies), which will inform the design of an R01-level trial.

Public health relevance
This project is directly related to Center for Population Health Research priorities, as it explores a novel means of health promotion and prevention of age-related physical frailty, which is designed to overcome barriers to access and promote autonomy in managing physical health. Thus, it is well-suited to address the needs of under-served and rural communities.